cDNA Microarray Reader Instrumentation

cDNA micro-array readers are invaluable tools for analysis of gene expression and for gene discovery through analysis of the fluorescent patterns of probes hybridized to a library of cDNA targets immobilized on a microscope slide. The fluorescence diagnostic instrumentation is based on a scanning confocal microscope in which laser excited fluorescence is spatially filtered and detected using a photomultiplier. Evaluation of 16,000 different gene fragments is possible on a single microscope slide. Identification of unwanted, background fluorescence signals with modifications to the optical filtration has resulted in a significant improvement to the signal to noise ratio. Thus, lower levels of gene expression can now be determined.